ACTG 258

The study goal is to determine the relationship between apolipoprotein epsilon genotype and the phenotype of Alzheimer's Disease. Specifically, we hypothesize that patients with probable Alzheimer's and different apo-e genotypes will have different patterns of cognitive impairment and different risks for non-cognitive complications of Aizheimer's, namely depression and psychosis.